Extension and Online Adaptation of the FITSTART parent-based intervention to reduce drinking among first-year students

Project Summary The proposed project seeks to adapt, optimize, and extend our successful brief parent-based intervention (PBI). While previous PBIs have focused solely on giving parents information about how to communicate with teens, the FITSTART intervention was designed based on the Theory of Planned Behavior (TPB) to motivate parents to engage with the information and apply it to their communication with their teens. Delivered to groups of parents during summer orientation sessions, FITSTART included a live social norms intervention to correct perceptions about how often other parents communicate with their students, how approving other parents are of underage drinking, and how often students will likely drink in college. Consistent with the TPB, we also presented information designed to change parents' attitudes about college alcohol use. This novel approach demonstrated robust short-term effects during students' first month on campus, reducing weekly drinks, the likelihood that non-drinking students would initiate alcohol use, and the likelihood that those already drinking would engage in heavy episodic drinking. However, the effects dissipated by the second semester and the live small-group format limits the extent to which FITSTART can be easily disseminated to parents nationwide. The current 3-year project will adapt FITSTART to create FITSTART+. We will employ technology we have developed over the past two years informed by the literature on virtual co-presence—a phenomenon by which persons inhabiting a shared online space can feel a sense of community—to create an online version of FITSTART that maintains the benefits of the live program while increasing the reach and scope of the intervention substantially. In Phase I we will employ Participatory Design Methods (PDM) to allow approximately 680 parents to help design the intervention's interface and content themselves through focus groups, surveys, and PDM exercises. Simultaneously we will work with a web designer and a New York Times bestselling author to create and adjust the online intervention platform and content based on feedback from parents. Then, in Phase II we will conduct a feasibility and efficacy trial of the final FITSTART+ program with a sample of 600 parent-student dyads. After students complete a baseline survey during July prior to their arrival on campus, parents will be randomized to FITSTART+ or a control program that corrects norms related to general college health behaviors rather than alcohol use. Importantly, this will test feasibility, not just efficacy. Thus, the program will be marketed to parents as it would be in a “real world” dissemination (i.e., parents will be told the program is being offered by the university for free rather than being told it is part of a research study). Students will complete follow-up surveys during the Fall and at the end of the Spring semester to assess short- and long-term alcohol use and consequences. If pilot results are promising, Parent FITSTART+ will be well-positioned for a large scale, multi-site R01 proposal to evaluate the efficacy of this cost-effective and easily-disseminated parent intervention both alone and in conjunction with existing student interventions.

Public health relevance
Project Narrative Despite a growing understanding that parents continue to shape adolescents’ alcohol use decisions even after students leave the home and matriculate to college, parent influence remains a severly underutilized resource in the fight to curb risky drinking on college campuses—partly because, to date, parent-based interventions (PBIs) have been ineffective at reducing heavy episodic drinking (HED). Recently, we were able to develop a PBI that influenced numerous indicators of student alcohol use, including HED, by combining the informational content that characterizes a typical PBI with a live group-based social norms intervention designed to motivate parents to engage with the informational content more deeply and to really apply it to their interactions with their child. The current project aims to adapt, optimize, and extend this successful intervention in 4 key ways: (1) by employing recent advances in “co-presence” technology that will allow us to move to online delivery of the intervention without sacrificing the benefits of a live group session; (2) by employing Participatory Design Methods (PDM) to allow over 600 parents to help design the intervention’s interface and content themselves through focus groups, surveys, and PDM exercises; (3) by delivering the intervention in four installments spread across the first year of college rather than a single session delivered during the summer; and (4) by augmenting the norms and information with engaging professional-quality video content featuring top experts on adolescent parenting.